The use of lorazepam for treatment of pediatric status epilepticus

The goal of this study is to obtain sufficient clinical data on the use of lorazapam for treatment of status epilepticus in pediatric populations, which will lead to FDA-approved labeling of lorazapam for this purpose.